Defining the female pragmatic language profile of autism and the broad autism phenotype

Summary
Pragmatic (i.e., social) language impairments are a defining feature of autism spectrum disorder (ASD), which
can impose significant burden on individuals throughout the lifespan. Strong evidence also suggests that this
clinical domain is influenced by genetic markers associated with ASD in clinically unaffected relatives,
constituting a principal component of the broad autism phenotype (BAP). Although sex differences in the
development of pragmatic language have been repeatedly demonstrated in the general population, sex-specific
differences in pragmatics in ASD and the BAP are woefully understudied, despite mounting evidence of a distinct
clinical phenotype among autistic females, and the strong impact of pragmatic skills on clinical outcomes and
well-being. Most studies of pragmatics in ASD have included only males or included so few females that they
were insufficiently powered to address the potential of sex-specific patterns of pragmatic skills in conversation,
narrative, or other crucial social-communication contexts where pragmatic skills play an essential role in social
functioning (including vocational success) across the lifespan. In this project, we will apply an armamentarium of
deep phenotyping methods to dissect the key features and contributors to the hypothesized sex-specific
pragmatic language profiles of ASD and the BAP that extend beyond traditional, categorically-defined diagnostic
boundaries, using a family-study design and including a representative ASD cohort enriched for females, ASD
parents, and respective control groups. Aim 1 will characterize the pragmatic language profile of females with
ASD and related, potentially sex-specific neurocognitive mechanistic skills and psychosocial outcomes. Aim 2
will conduct parallel questions in the BAP. Finally, Aim 3 will estimate the incidence of sex-specific pragmatic
profiles of ASD and BAP in the general population via crowdsourced pragmatic phenotyping. Our preliminary
studies demonstrate strong evidence for complex sex-specific patterns of pragmatic abilities in ASD that may be
comprehensively and sensitively measured with the complement of gold-standard hand-coding methods and
advanced fine-grained computational- and machine-learning-based approaches proposed in this project.
Together, the rich and extensive data produced will contribute to our understanding of the fine-grained skills
underlying the sex-based heterogeneity in ASD, and the mechanistic, potentially sex-specific origins of
pragmatics as an important clinical domain. Our findings will move us closer to achieving long-term translational
goals to advance understanding of the sex-specific differences in pragmatic language impairment in ASD in
order to improve the prediction of clinical outcomes and help guide future interventions and treatment in ASD.

Public health relevance
Project Narrative Challenges with using language in social contexts, such as conversational interactions, impact autistic individuals across the spectrum and throughout the lifespan. Efforts to understand the causes of these challenges have primarily focused on autistic males, leaving unanswered critical questions about how social language use might be impacted differently for autistic females and contribute to clinical outcomes and well-being. This project addresses this question by studying sex-specific characteristics of social language abilities and their behavioral markers in autism, in order to improve prediction of clinical outcomes and help guide future interventions and treatment in autism.